Socially-Assistive Robots for Alzheimer's (SARA)

Project Summary/Abstract The objective of this Phase I Socially-Assistive Robots for Alzheimer’s (SARA) effort is to design and demonstrate the feasibility of a socially integrative and supportive robot system to enhance the connectedness, caregiving, well-being, and quality of life of older adults experiencing early to middle stage Alzheimer’s disease (AD) and AD-related dementias (ADRD). One in 10 people 65 and older has AD, with estimates of up to as many as 5.5 million Americans currently living with AD. Because of the loss of cognitive function and subsequent changes in employment and reduced engagement with social groups and hobbies, AD/ADRD patients often experience loneliness and social isolation, and the considerable challenge of caring for these individuals often causes similar effects in caregivers. If successful, SARA will have significant impact on AD/ADRD patient care and quality of life, reducing loneliness and social isolation. The specific aims of this two-year pilot study are to: (1) adapt commercial robot and peripheral hardware to create accessible interactions for AD/ADRD patients; (2) design and develop the robot interaction software to provide rich, supportive interaction; and (3) assess the feasibility, usability, and acceptability of SARA with AD/ADRD older adults and their caregivers. SARA employs user-community-driven design processes and evaluations to address key challenges surrounding how to best apply commercial robots and engaging interaction methodologies to improve AD/ADRD patient care. We will develop SARA through an iterative development process that produces and evaluates three versions of the system during the Phase I effort. SARA is significant in three ways. SARA reduces loneliness by providing robotic social interactions. SARA reduces social isolation by connecting the patient more closely with family, friends, and caregivers, both directly and through social media. SARA provides social assistance in three ways: (1) through automated reminders and question answering for everyday information that is easily and often forgotten by patients; (2) conveyance of health regimens (e.g., What can I have for lunch? Should I still exercise today?); and (3) monitoring for caregivers. SARA contains three central innovations. First, to create a user experience that is well tuned to the needs of patients and caregivers, SARA is created with significant feedback from AD/ADRD patients and caregivers. Second, to enable us to build on multiple robotic platforms that can meet this user experience, and to provide future extensibility, SARA features a platform-agnostic software and hardware framework that can integrate with a wide range of consumer social robots. Third, to create engaging, believable, and effective interactions with AD/ADRD patients, SARA uses and extends an AI-based architecture, Hap, which is specifically designed to create socially engaging interactive characters and robots that provide enjoyable and stimulating interactions.

Public health relevance
Project Narrative As many as 5.5 million Americans may have Alzheimer’s disease, an irreversible, progressive brain disorder that slowly destroys memory and thinking skills, eventually impairing the ability to carry out even the simplest tasks. Socially-Assistive Robots for Alzheimer’s (SARA) is a socially integrative and supportive robot to enhance the connectedness, caregiving, well-being, and quality of life of older adults experiencing early to middle stage Alzheimer’s disease (AD) and AD-related dementias (ADRD). SARA helps alleviate the social isolation and loneliness that AD/ADRD can have on individuals and their caregivers, improving quality of life, reducing the monetary and social costs of care, and increasing the overall access and impact of care.